Measuring, Modeling, and Modulating Cross-Frequency Coupling

PROJECT SUMMARY Although rhythms are a prominent feature of brain activity, the role of rhythms in brain function (and dysfunction) remains elusive. Rhythms have been proposed to organize information transfer within and between brain regions by modulating neural excitability at different time scales. Rhythms have also been proposed to interact across these different time scales, a phenomenon labeled cross-frequency coupling or CFC. Clinical and experimental observations have identified many different types of CFC, such as coupling between the phase of a low frequency rhythm and the amplitude of a high frequency rhythm (phase-amplitude coupling), or between the phases of two different frequency rhythms (phase-phase coupling). Many functional roles for CFC have been proposed, including in working memory, neuronal computation, communication, learning and emotion. Despite the mounting experimental evidence for CFC, three important challenges remain that limit understanding of this phenomenon. First, many different data analysis methods have been developed to characterize CFC, with each method typically focused on one type of CFC. Choosing an inappropriate method weakens statistical power and introduces opportunities for confounding effects. Second, analysis of CFC typically occurs post hoc, prohibiting opportunities to modulate CFC during an experiment. New methods are needed to assess CFC in real time while limiting the impacts of potential confounds. Third, the mechanisms that produce CFC are not known. While computational models developed to explore these mechanisms provide important insights, these models have been mainly restricted to synaptic mechanisms of rhythm generation and associations between two types of rhythms. New models are needed to examine the role of other rhythms and rhythm generating mechanisms in CFC. Inclusion of more realistic biological features in simulations of neural rhythms facilitates exploration of a new challenge: how electrical stimulation modulates CFC. In this project, an interdisciplinary research group consisting of a statistician, a mathematician, and a psychiatrist-engineer will analyze, model, and modulate cross-frequency coupling. To do so, the team will develop and apply a statistical inference framework suitable for real time analysis of CFC, and apply this framework to analyze - and modulate with electrical stimulation - in vivo recordings from rat cortex and subcortex. The team will also develop computational models of CFC, to link the observed data to cellular mechanisms, and create hypotheses testable in the in vivo experiments. Completion of the proposed research will represent a significant step forward toward a more complete understanding of cross-frequency coupling, and toward a system for exploring and testing innovative methods for its modulation.

Public health relevance
PROJECT NARRATIVE Cross-frequency coupling is a common - yet poorly understood - feature of brain electrical activity. Characterizing the dynamics, and understanding the mechanisms, of cross-frequency coupling remains a challenge. To address this challenge, an interdisciplinary team of researchers will analyze, model, and modulate voltage data recorded from two brain structures to assess and perturb cross-frequency coupling. !